IGF::OT::IGF TASK ORDER 39: EVIDENCE-BASED APPROACHES FOR OPTIMIZING EMPLOYMENT OUTCOMES AMONG CANCER SURVIVORS

Evidence-Based Approaches for Optimizing Employment Outcomes among Cancer Survivors In-Person Meeting